MWAS+ – A Novel Drug Repurposing Strategy for ADRD Prevention

Nearly 6 million Americans ≥65 years suffer from Alzheimer’s disease (AD) or AD-related dementias (ADRD).
AD/ADRD poses significant emotional, physical, and financial burdens on patients, families, and societies. There
is no cure for AD/ADRD, and apart from the June 2021 controversial “accelerated approval” of aducanumab, no
new symptom-modifying drug has been approved since 2003, highlighting the need for AD/ADRD prevention.
Currently, no drug is available to delay the onset of AD/ADRD. The prohibitive cost of developing new drugs or
repositioning partially developed drugs for AD/ADRD treatment would be even more prohibitive for AD/ADRD
prevention as the latter would require larger sample size and longer follow-up. An alternative cost-effective and
efficient approach is to repurpose from >20,000 FDA-approved drugs for AD/ADRD prevention. However,
repurposing of drugs is often accidental. A timely and purposeful discovery of new clinical benefits of old drugs
requires a systematic examination of large comprehensive clinical databases with longitudinal records and long
follow-up, using innovative, sophisticated mixed machine learning and statistical tools. This application has been
prepared in response to the NIA PAR-20-156 entitled “Translational Bioinformatics Approaches to Advance Drug
Repositioning and Combination Therapy Development for Alzheimer’s Disease”. We propose a 3-Step
Medication-Wide Association Study Plus (MWAS+) approach. Our MWAS+ will employ innovative explainable
deep (machine) learning, a powerful artificial intelligence tool for noisy, nonlinear data. We will use Veterans
Affairs (VA) electronic health record (EHR) data of >3 million Veterans ≥65 years (54,411 women; 202,000
African American), ~600 prescription drugs (each used by ≥10,000 Veterans), ≥10 years of history and ~200,000
AD/ADRD cases. In Step 1 (Aim 1), we will conduct a hypothesis-free exploratory case-control MWAS (akin to
GWAS) to identify drugs associated with AD/ADRD in the VA EHR data. Drugs identified in Aim 1 will be reviewed
by a panel of experts for plausible mechanistic pathways and 10 drugs will be recommended for hypothesis
testing in Step 2 using VA EHR data (Aim 2) and external validation in Step 3 using Medicare data (Aim 3). In
Aims 2 and 3, we will conduct outcome-blinded cohort studies using new user design. Marginal structural models
and other causal inference methods, including doubly-robust inference procedures, will be used to estimate time-
fixed (“intent-to-treat”) and time-varying (“as-treated”) effects of those drugs on incident AD/ADRD. The proposed
project is highly significant because it will rigorously accelerate the identification of already approved drugs that
have a high potential to be repurposed to delay and prevent AD/ADRD, a rapidly growing public health crisis.
The project is innovative as it combines state-of-the-art deep learning and statistical methods to conduct an
MWAS+ study that has never been used before for AD/ADRD prevention. In addition, the VA EHR contains high
quality clinical data including pharmacy fill records and rich phenotypic information including fitness and frailty.
Findings from this project will inform future clinical trials to repurpose approved drugs for AD/ADRD prevention.

Public health relevance
Nearly 6 million older Americans have dementia that causes difficulty with reasoning and remembering, and yet there are no drugs to cure or prevent it. The development of new drugs typically costs about $3 billion and takes about ten years. We propose an innovative artificial intelligence-based approach to examine data from millions of Veterans and their medications to efficiently identify drugs that may delay onset of dementia.